New, Non-Invasive (No-Puff, No-Touch), Tonometry Method: Remote photonic IOP biomonitoring using the damping factor of transitional oscillations after terminating its stimulation by a sound wave.

Project Summary/Abstract
Glaucoma is a major source of irreversible blindness affecting more than 5 million Americans and costing the
U.S. economy $2.86 billion/year. Current glaucoma treatments include frequent eye-contacting intraocular
pressure (IOP) measurements requiring anesthetic eye drops and interpretation by trained healthcare
professionals which introduces bias. Our methodology, Photonic IOP Biomonitoring (PIB), allows high-
precision, non-contact, non-air puff, reproducible and semi-continuous IOP monitoring without clinician
interpretation. PIB measures sound wave induced scleral oscillations by monitoring laser speckle patterns.
Physical modelling with machine learning (ML) algorithms deduce IOP. Ultimately, our goal is miniaturization
into monoculars or eyeglasses allowing patients to take real-time IOP measurements relayed to physicians for
treatment recommendations and medication dispensing through a smart phone-based system. Aim 1:
Develop a physical model to seed ML algorithms for IOP resolution, accuracy and repeatability. ML is
seeded with a random initial state when no test subject knowledge is available. In contrast, a physical model
based on Newton’s equations of motion indicates the value of a continuous variable (IOP) given physical
parameter values characteristic of the test subject. Ultimately, a physical model would identify IOP without
further ML class regression. PIB free from ML optimization eliminates the need for calibration and physician
interpretation. Output of this physical model will seed simpler ML algorithms to achieve better resolution,
accuracy and repeatability. Hypothesis 1a: Porcine eye PIB measurements can achieve resolution of ≤1
mmHg. Hypothesis 1b: Porcine eye PIB IOP measurements will yield accuracy and repeatability of 2 mmHg
standard deviation or less. These hypotheses will be tested by measuring porcine eyes with IOP within the
range of 5 mmHg up to 60 mmHg. Aim 2: Implement pupil monitoring: An eye position monitoring system
will aid subjects in keeping their pupil directed at the pupil monitor. Deviations from this nominal position will
turn off the laser and pause data acquisition. Hypothesis 2a: Monitoring eye position will improve patient safety.
Hypothesis 2b: Temporal filtering of large deviations will improve measurement accuracy and repeatability.
Feasibility will be assessed by 1) showing that light entering the porcine pupil cannot exceed a threshold below
the standard safety criteria of 0.6mW, and 2) by showing that IOP prediction accuracy, precision and
repeatability improves in pig eye tests by incorporating eye position data. Aim 3: Assess PIB Repeatability in
Human Eyes: PIB tests of 30 healthy human eyes (15 healthy human subjects) in Phase I will inform the
development roadmap in a subsequent Phase II trial. Hypothesis 3a: PIB repeatability in human eyes is equal
to that of a comparable set of pig eyes Aim 4: Safety and Comfort: We will monitor for patient comfort and
signs of corneal superficial punctate epithelial erosions or dryness. Hypothesis 3b: PIB will be found innocuous
as evaluated by comparable or fewer adverse events than GAT and comparable or greater comfort.

Public health relevance
Project Narrative More than 5 million Americans have glaucoma, a major source of irreversible blindness that costs the U.S. economy $2.86 billion dollars every year in direct costs and productivity losses. Current glaucoma treatments include frequent eye-contacting intraocular pressure (IOP) measurements requiring anesthetic eye drops and interpretation by trained healthcare professionals which introduces bias. We will study Photonic IOP Biomonitoring (PIB), a high-precision, non-contact, non-air puff, IOP monitoring method based on sound wave induced eye surface vibration which can be performed by the patient outside of the clinic without the need for clinician interpretation.